TRUE HAVEN: TRUsted rEsidents and Housing Assistance to decrease Violence Exposure in New Haven

PROJECT SUMMARY
Community gun violence kills more than 15,000 people each year who are disproportionately younger, Black
men. In addition, people living in communities with high rates of gun violence experience long-term negative
physical and mental health effects from persistent trauma. At the root of neighborhood conditions that allow
this violence and trauma to persist are generations of structural racism, including redlining policies and mass
incarceration, which contribute to systemic disinvestment in these neighborhoods and disruption of community
bonds. This proposal challenges long-standing structurally racist policies that limit resources and addresses
the social context that stymies positive relationships by permitting and normalizing trauma after exposure to
gun violence by applying a counteracting positive, systemic community-level approach to change the
context within which intergenerational cycles of gun violence, trauma, and incarceration persist. Dr. Brita Roy,
MD, MPH, MHS, Director of Population Health at Yale Medicine and core faculty at the Yale Center for
Research Engagement, and Virginia Spell, CEO of Urban League of Southern Connecticut, a civil rights
organization, have partnered with stakeholders across New Haven, Connecticut, to design and test a program
to reduce gun violence by addressing structural racism. TRUE HAVEN: TRUsted rEsidents and Housing
Assistance to decrease Violence Exposure in New Haven is a multi-level, multi-component, assets-based
intervention to increase the stability, wealth, and well-being of neighborhoods affected by gun violence by: (1)
setting up a citywide community stakeholder-led governance structure to oversee the program and identify and
address racist policies, (2) increasing housing stability by enrolling 400 families affected by incarceration each
year in a program that couples comprehensive financial education with rental assistance or down-payment and
loan assistance, and (3) providing greater support for mental health and well-being by training trusted
community members (e.g., barbers, educators, faith leaders, youth mentors) in trauma-informed counseling
techniques to recognize and support those affected by the trauma of gun violence. We will target
implementation of this intervention package to individuals and families affected by incarceration residing within
six New Haven neighborhoods with high rates of gun violence. We will perform a hybrid type 1
effectiveness/implementation study to assess the effects of TRUE HAVEN on neighborhood rates of incident
gun violence using a stepped wedge study design and identify organizational and policy factors that act as key
barriers and facilitators to TRUE HAVEN implementation. We will also track the number and types of racist
policies addressed and project their community-wide impact using a simulation model that can be adapted by
other communities aiming to tackle structural racism. This study will yield a roadmap for how cities can
effectively and systematically tackle structural racism to reduce gun violence and improve community health
and well-being.

Public health relevance
PROJECT NARRATIVE To break the cycle of persistent community gun violence that primarily affects low-income, Black, and Latinx neighborhoods, this proposal aims to challenge long-standing structural racism, manifest through redlining and mass incarceration, and the social context that permits and normalizes trauma after exposure to gun violence. TRUE HAVEN: TRUsted rEsidents and Housing Assistance to decrease Violence Exposure in New Haven is a multi-level, multi-component, strengths-based, community-driven intervention focused on reducing gun violence by (1) improving housing stability through providing financial assistance coupled with comprehensive financial education and (2) fostering greater support for mental health by training a trusted network of community members in trauma-informed counseling. We will test the effectiveness of TRUE HAVEN within specified neighborhoods using a step wedge design, while also identifying intervention facilitators and barriers and project long-term outcomes using a simulation model, yielding a roadmap for how cities can effectively and systematically tackle structural racism to reduce gun violence and improve community health and well-being.